Prophylactic colectomy intentions in HNPCC patients

DESCRIPTION (provided by applicant): Hereditary non-polyposis colorectal cancer (HNPCC) is associated with up to an 80 percent lifetime risk of developing colorectal cancer and a 40 to 50 percent chance of a metachronous tumor after partial colectomy for the disease. For these patients, prophylactic colectomy has been proposed as a potential risk management alternative to a lifetime of intensive surveillance by colonoscopy. The highly personal nature of risk management decisions has been recognized in the development of individualized genetic counseling services. However, prior psychosocial research in this area has tended to use linear statistical techniques in which clinically important details are lost in an overly broad, one-size-fits-all model that is difficult to apply in a one-to-one counseling session. We propose an innovative approach based on the Cognitive-Social Health Information Processing (C-SHIP) model in which we will explore how these factors are organized into meaningful patterns or types that can translate readily into tailored counseling recommendations. Specific aims of this study are: 1)To assess levels of interest in prophylactic colectomy among HNPCC patients; 2) To identify distinctive decision types based on profiles of perceived pros and cons of prophylactic colectomy; and 3) To explore the pattern of relations between decision types and counseling-related outcomes (level of interest in colectomy, cancer-specific anxiety, and colonoscopy adherence). We will conduct a one-time cross-sectional telephone survey of 320 HNPCC patients (defined as either carriers of a mutated mismatch repair gene associated with HNPCC or those with a personal or family history meeting published criteria for HNPCC). Using cluster analysis we will create a taxonomy of decision types. Prior research leads us to expect at least three types: Disengaged, Risk-Focused, and Ambivalent. We hypothesize that each type will have a different pattern of relations with the outcome variables (e.g., Risk-focused types will show high interest in surgery, high anxiety, low avoidance, and high colonoscopy adherence, whereas Ambivalent types will show high interest in surgery, high anxiety, high avoidance, and low colonoscopy adherence). Understanding these patterns will enhance the ability of physicians, genetic counselors, and other providers to help their patients make well-informed, thoughtful decisions about the preventive strategy that will best protect their health, emotional well-being, and quality of life.